Ghana IntegRative Approach to Cancer ResEarch Training: The Grace Program

Project Summary/Abstract
Cancer incidence is significantly increasing in many sub-Saharan Africa countries necessitating a shift in
training and research to address this growing problem. Years ago Ghana recognized this problem and
identified cancer sites for prioritization for both research and clinical care in their National Cancer Control Plan.
These cancers include breast (BCa), cervical (CxCa), head and neck (HNCa) and prostate cancer (PCa). To
address the goals set forth in the national cancer plan Moffitt Cancer Center (MCC) faculty have been
collaborating with the Korle-Bu Teaching Hospital within the University of Ghana (UG), and the Ghana College
of Physician and Surgeons (GCPS) for the past five years to build collaborative research and cancer clinical
care capacity. This work started initially with a focus on PCa and HNCa, two cancers of common concern and
interest, as the incidence and mortality associated with these cancers disproportionally affects Ghanaians and
US African Americans. Recognizing the need to expand research to BCa and CxCa in Ghana the MCC-Ghana
collaboration is poised to expand efforts to these two additional cancers and to expand existing research and
training collaborations to create a comprehensive and structured program with greater depth and breadth. We
propose to expand the existing list of collaborating institutions in Ghana to include the University of Ghana
Medical School (UGMS), School of Public Health (UGSPH), and Nursing School. In addition, we plan to adapt
a comprehensive cancer research training program developed as part of a completed Fogarty D43 Morocco
grant, to accelerate the implementation of cancer research training in Ghana. The overall goal of this proposal
is to develop a new generation of multidisciplinary global health cancer researchers at MCC and UG by
implementing programs that will strengthen and expand institutional capacity to broadly conduct cancer
research - Ghana IntegRative Approach to Cancer ResEarch Training: The GRACE Program. Specifically, we
propose the following: 1. Build and implement cancer research training and capacity (Lectures and Workshops
and an Applied Research Experience); 2. Fund Team-Science Research, and; 3. Transfer and sustain the
Ghana cancer research training program. At the end of five years we will have trained a new generation of
fellows and junior faculty (~125-150) and embedded into the Ghana medical education system a sustainable
cancer research training program to support continued cancer research growth in Ghana. The proposed training
program will advance research among physician scientists practicing oncology and recruit talented
professionals from related health fields to conduct cancer research, thereby rapidly expanding cancer research
in Ghana. By engaging those from multiple disciplines, the proposed program will strengthen Ghana’s existing
national and multidisciplinary cancer-specific research teams. Ultimately, our goal is to have this training
program serve as a bridge between academic, policy makers, and public health communities.

Public health relevance
Cancer incidence is significantly increasing in Ghana, a country that has a nidus of cancer researchers, but requires a larger cadre of researchers trained across multiple cancer disciplines to address the growing cancer problem. We propose a 5-year cancer research training program for Ghana, “Ghana IntegRative Approach to Cancer ResEarch Training: The GRACE Program,” that builds on existing research collaborations between the Moffitt Cancer Center and the Ghana health systems (i.e. University of Ghana Medical School, School of Public Health, Korle-Bu Teaching Hospital, and the College of Physicians and Surgeons), and leverages existing educational materials that will provide short-, medium, and long-term cancer research training to ~150 trainees, that can be sustained beyond the funding period.